Deciphering RNA Splicing Control of Lipid Metabolism and Alcoholic Liver Injury

Project Summary/Abstract
Our Overall Objective is to unravel the pathogenesis of alcohol-associated liver disease (ALD) and identify new
therapeutic targets. ALD is one of the leading causes of morbidity and mortality worldwide among chronic liver
diseases, but there are no FDA-approved treatments for ALD. Our recent studies have identified lipogenesis
as an important factor promoting ALD. However, the molecular mechanisms for lipogenesis are still poorly
understood. Alternative splicing is a critical mechanism that increases transcriptome complexity and expands
proteome diversity and function. To date, little is known about the role of serine-arginine rich protein kinase
2 (SRPK2), a critical splicing regulator, in chronic liver disease. Intriguingly, our preliminary results have
shown that SRPK2 abundance is upregulated in rodents and humans with ALD, which is associated with the
induction of the lipogenic transcription factor SREBP-1. These data have prompted us to determine the potential
role of SRPK2 in the pathogenesis of ALD. Overexpression of SRPK2 is sufficient to increase lipogenic gene
expression in hepatocytes. Conversely, adenoviral knockdown of SRPK2 alters pre-mRNA splicing of lipin 1, a
lipogenic regulator, and attenuates alcoholic steatosis in mice. While fibroblast growth factor 21 (FGF21) is
emerging as a potential therapeutic candidate for diabetes in clinical trials, knowledge regarding the role of
the hepatokine FGF21 in alternative splicing dysregulation during ALD is lacking. A pilot study shows that
FGF21 overexpression in transgenic mice ameliorates alcoholic steatosis and lipotoxicity; this beneficial effect
is associated with SRPK2 inhibition. Thus, our Central Hypothesis is that SRPK2-mediated regulation of
alternative splicing triggers lipid accumulation and promotes alcoholic liver injury, and inhibition of SRPK2 has
therapeutic implications for ALD. To expand on these exciting observations, we propose three Specific Aims:
1) To elucidate the molecular mechanism by which SRPK2-mediated regulation of alternative pre-mRNA is
coupled to the control of lipid metabolism and promotes the progression of ALD; 2) To determine whether the
hepatokine FGF21 functions as a novel regulator of SRPK2 in the control of triglyceride and cholesterol
metabolism in ALD; and 3) To assess whether targeting SRPK2 has therapeutic implications for ALD. We will
comprehensively test our hypothesis with cutting-edge cellular, molecular, and biochemical methods for pre-
mRNA splicing, hepatocyte-specific FGF21 knockout mice, and in vivo pharmacological and molecular
manipulation approaches. Complementary state-of-the-art techniques, including alternative splicing profiling and
lipidomics analyses, will allow us to characterize aberrant changes in pre-mRNA splicing machinery and lipid
metabolites in the livers of alcohol-fed mice. Overall, accomplishing this project will identify pre-mRNA splicing
mechanisms that contribute to ALD pathologies and will provide a rationale for targeting elements of the SRPK2-
regulated splicing process as a novel therapeutic strategy for ALD, such as FGF21.

Public health relevance
Project Narrative Alcohol-associated liver disease (ALD) is one of the leading causes of morbidity and mortality worldwide among chronic liver diseases; unfortunately, no FDA-approved treatments are available, due to an incomplete understanding of its molecular mediators. The objectives of this project are to discover the new function of the serine-arginine protein kinase 2 (SRPK2) on alcohol-induced pre-mRNA splicing in hepatocytes, to elucidate how SRPK2-mediated regulation of pre-mRNA splicing modulates alcohol-induced abnormalities in lipid metabolism in ALD, and to investigate whether targeting SRPK2 by fibroblast growth factor 21 (FGF21), a hepatocyte-derived hormone, delays and reverses the progression of ALD. The proposed research is relevant to the mission of NIAAA and public health because the knowledge gained may provide a rationale for designing innovative therapeutic strategies, such as a long-acting form of FGF21, as pharmacological interventions for human ALD.